The MObile Health InterVEntion in Pulmonary Arterial Hypertension (MOVE PAH) Study

ABSTRACT
Patients with pulmonary arterial hypertension (PAH) have reduced health related quality of life (HRQOL) and
impaired exercise capacity. Despite fourteen approved therapies, most patients die within ten years. This grim
fact underscores the need to develop interventions that improve HRQOL, particularly targeting mechanisms
that are non-redundant to existing PAH therapies. Increasing physical activity is highly efficacious in PAH,
resulting in six-minute walk distance (6MWD) and HRQOL improvement that often exceeds the effect of
medications. Prior activity studies required inpatient rehabilitation, which is impractical, hard to sustain, and
poorly scalable to a rare disease. Moreover, rehabilitation for PAH is not typically reimbursed by insurance in
the United States, highlighting the need for alternatives to promote physical activity. This application builds on
a recently-completed, NIH-funded pilot and feasibility trial of a mobile health (mHealth) intervention in PAH. In
the pilot, subjects wore a Fitbit device and were randomized to either usual care or a fully automated “smart
text” intervention. Text content was based on behavioral change theory and personalized to each subject.
Texts were sent to the intervention arm 3 times/day with encouraging messages based on real-time activity
data. Each subject had a personalized step count target which increased by 20% every 4 weeks. At the end of
12 weeks, the intervention arm took 1019 more steps per day than the control arm, an increase of 20% over
baseline. We now hypothesize that increasing step counts will improve HRQOL in patients with PAH. We
propose a randomized trial of smart texts versus usual care for 6 months. We will randomize 100 PAH patients
to the mHealth intervention or usual care. All enrollment, monitoring, and data collection will occur remotely at
Vanderbilt. We will enroll subjects across the United States, increasing generalizability. Our enrollment targets
are feasible because we are supported by two large, existing PAH cohorts – the NIH-funded PVDOMICS
Consortium and the Pulmonary Hypertension Association Registry. R61 Milestones (Year 1): IRB approval;
establish DSMB; create REDCap database; Data Use Agreements; programming of text intervention;
enrollment of first 10 subjects. In Aim 1 (primary endpoint), we will test the effect of a text-based mHealth
intervention on HRQOL in PAH using the PAH-specific emPHasis-10 questionnaire. In Aim 2 (secondary
endpoint), we will test the effect of an mHealth intervention on exercise capacity, measured by a highly feasible
and reproducible supervised home-based 6MWD test. In an exploratory aim, we will examine the effect of the
intervention on time to clinical worsening (composite of PAH therapy escalation, PAH hospitalization, and
death) one year after randomization. This proposal will test a novel, highly scalable, and affordable mHealth
intervention to improve clinically meaningful outcomes in patients with PAH.

Public health relevance
NARRATIVE Increasing physical activity improves quality of life and functional capacity in patients with pulmonary arterial hypertension (PAH), a rare disease with a median survival of seven years. We recently demonstrated in a randomized pilot trial the feasibility of increasing step counts in patients with PAH using a text-based mobile health intervention. Accordingly, we now propose a larger, longer-term study to test whether increasing step counts through a mobile health intervention will improve quality of life in patients with PAH.